Advancing Science, Practice, Programming and Policyin Research Translation for Children's Environment Health (Asp3ire)

DEVELOPMENT CORE
PROJECT SUMMARY
The Development Core of the Oregon State University Center for Advancing Science, Practice,
Programming and Policy in Research Translation for Children’s Environmental Center (ASP3IRE
Center) provides scientific rigor, time-sensitive funding for innovative research and training for
scientists in children’s environmental health research. The Development Core will strategically
develop data science methods for precision CEHRT and attract, retain and support a cadre of highly
qualified interdisciplinary CEHRT scientists. Our Development Core will leverage CEH concerns
brought forth through citizen engagement and examine how, why and where environmental hazards
or concerns exist, using data science methods. In addition, the Development core will fund, train and
mentor teams of innovative scientists focused on research projects in CEH. Specifically, this includes
funding 15 rapid cycle catalyst projects with 1-year timelines. The Development Core is well-situated
within the ASP3IRE Center to provide strategic support to scientist from a variety of disciplines, who
are interested in furthering their knowledge and training in CEH research. Our core will work closely
with our trusted conduits (extension, early childhood educators and CCOs), as well as all cores within
the ASP3IRE Center.